CHEMO-IMMUNOTOXIN THERAPY AGAINST HUMAN TUMORS XENOGRAFTED IN AHTYMIC MICE

The antitumor effects of two immunotoxins (IT) were evaluated in vitro and in vivo against the human ovarian carcinoma cell line, OVCAR-3. The ITs used were an anti-carcinoma MoAb coupled to Pseudomonas exotoxin (NR-LU-10/PE) and a IT composed of the recombinant A chain of ricin covalently attached to a MoAb directed to the transferrin receptor (454Al2/rRTA). Protein synthesis was inhibited in a dose-dependent manner in OVCAR-3 cells incubated in vitro with either NR-LU-10/PE or 454Al2/rRTA (IC50=1 and 75 ng/ml) respectively. Concomitant incubation in vitro of OVCAR-3 cells with NR-LU-10/PE or 454Al2/rRTA and a non-cytotoxic concentration of rhIFN-alpha was shown to potentiate the inhibitory activity of the ITs via a mechanism distinct from antigenic regulation. Studies showed that the MST of mice injected i.p. with 4,000,000 OVCAR-3 cells was 46 days. Cohorts of mice that received intracavitary treatment beginning five days post-tumor cell injection with either 0.25 or 0.5 (mu)gs of NR-LU-10/PE every other day for a total of ten treatments exhibited significantly increased MSTs of 63.0 and 104 days respectively (P=0.0001). Likewise, the i.p. injection of either 2.5 or 10 (mu)gs of 454Al2/rRTA administered by an identical regimen, resulted in MSTs of 89.0 and >120.0 days, respectively (P=0.0001). When rhIFN-alpha was administered i.p. in conjunction with these doses of either IT, a significant increase in MST was observed in comparison to mice given IT alone. The combination of 50,000 U rhIFN-alpha and 0.25 (mu)gs NR-LU-10/PE resulted in 67% long-term survivors compared to only 13% survival of mice given IT alone. Similarly, 2.5 (mu)gs of 454Al2/rRTA plus rhIFN-alpha resulted in 89% long-term survivors compared to 454AI2/rRTA alone (29%). Preliminary studies have revealed that a human colon line expressing the MDR gene, Ht-29(R), is highly resistant to multiple i.p. treatments of vincristine (2mg/kg). Investigations are underway to attempt to reverse this resistance in vivo utilizing various drugs and biological agents.